ACUTE EFFECTS OF TRIAMTERENE ON KIDNEY FUNCTION

To determine acute effects of Triamterene on glomerular filtration rate and effective renal plasma flowrate in combination with diuretics and alone. To determine if alkalinization of urine modifies these acute effects.